SOX17/RUNX1 Axis Regulates Endothelial Cell Fate in the Pathogenesis of Pulmonary Arterial Hypertension

Project Summary/Abstract:
Pulmonary arterial hypertension (PAH) is a progressive disease characterized by an obliterative vasculopathy of
the distal pulmonary circulation. Adverse structural remodeling and increased pulmonary vascular resistance
result in cardiac hypertrophy and ultimately failure of the right ventricle, with annual mortality averaging 10%.
Current therapies can improve symptoms and delay disease progression, but there is no cure. There is a critical
need to develop new therapies that effectively halt and reverse the disease by targeting the cellular and
molecular mechanisms underlying the pathophysiology of PAH. In Sox17 mutant PAH patients, we postulate
that loss-of-function mutations in the Sox17 gene result in insufficient upregulation of Sox17 during normal
reparative responses to vascular injury allowing increased RUNX1 signaling to drive aberrant angiogenesis.
Thus, our central hypothesis is that loss of repression of Runx1 by endothelial SOX17 predisposes to the
development of PAH through impaired arterial endothelial differentiation and aberrant angiogenesis. To test our
hypothesis, we plan the following specific aims: Aim 1. Determine if endothelial SOX17 deficiency leads to higher
susceptibility of developing PAH. Aim 2. Determine if SOX17/RUNX1 imbalance leads to impaired arterial
differentiation and aberrant angiogenesis following SuHx-PH induction. Aim 3: Determine if Sox17 mutant PAH
patient iPSC-derived ECs have impaired arterial differentiation and defective angiogenic capability.

Public health relevance
Project Narrative: Pulmonary arterial hypertension (PAH) is an incurable and fatal disease. There is a critical need to develop new therapies that effectively halt and reverse the disease by targeting the cellular and molecular mechanisms underlying the pathophysiology of PAH. The long-term goal of this project is to elucidate pathogenic mechanisms in PAH and develop novel curative therapies for this disease.